Reaching Equity in ACess to Home Dialysis And Re-Transplantation (REACH-DART)

PROJECT ABSTRACT
Kidney transplantation and home dialysis are the preferred treatment modalities for end-stage kidney disease
(ESKD) given the better quality of life and lower cost of these modalities compared with in-center hemodialysis.
However, in patients with graft failure, rates of preemptive re-listing for a second kidney transplant and use of
peritoneal dialysis (PD) are suboptimal, especially in Black and Hispanic kidney transplant recipients (KTRs).
While barriers in access to transplantation or PD in transplant-naïve patients have been attributed to lack of
patient awareness of their kidney disease, late referral for subspecialty care, and inadequate education, these
factors should not apply to a population that already received a kidney transplant, were likely exposed to
dialysis before their first transplant, and who have access to nephrology care. Disappointingly, only half of
KTRs treated with PD before their kidney transplant choose to return to this modality following graft failure, and
only 15% of patients with graft failure are relisted preemptively for a second kidney transplant. The rate of PD
use and relisting is particularly low in Black and Hispanic KTRs with graft failure. Identifying barriers that can
be addressed to improve access of former KTRs to home dialysis and repeat transplantation will not only
improve the outcomes of patients with graft failure, but also inform our understanding of the roadblocks that are
present even when access to care is unlikely to be the explanatory factor. In Aim 1, we propose to model the
time spent in the advanced stages of graft dysfunction and determine whether there are racial or ethnic
disparities in this time, which is critical for the preparation of patients for the next phase of their disease. We
will then determine if the time spent in the advanced stages of graft dysfunction is associated with access to
PD or re-registration on the waitlist for a second kidney transplant. In Aim 2, we will perform semi-structured
interviews with patients, dialysis providers, and transplant providers to understand their perceptions of the
barriers to PD and preemptive relisting. We will then use the data derived from these qualitative interviews to
develop a survey that will be administered nationally to confirm the importance of these barriers and identify
strategies that can be used to surmount these barriers. In Aim 3, we will examine system-level factors that
may contribute to disparities in preemptive relisting on the national waitlist and PD access, including variations
in the use of objective assessments of frailty during candidacy evaluations and the frequency of follow-up
contact between KTRs and their transplant center peri-graft failure. To accomplish our aims, we will leverage
data from the United States Renal Data System that will be linked to Medicare, Medicaid, and Optum claims
data. In a subset of patients, we will collect more granular local data from electronic health record systems to
enrich these administrative data. The data from this proposal will inform the interventions, best practices, and
policies that are needed to promote access to repeat transplantation and PD.

Public health relevance
PROJECT NARRATIVE Despite a history of successfully receiving a kidney transplant, patients with graft failure have wide variations in their access to preemptive listing and peritoneal dialysis. The goal of this study is to understand barriers to the pursuit of PD and re-listing in patients who develop graft failure, and to identify modifiable factors that can be intervened upon to improve access to these preferred modalities of kidney replacement therapy, particular as it applies to disadvantaged populations.